Critical functions of the gut microbiota that mediate recovery from recurrent Clostridium difficile infection

ABSTRACT
Recurrent Clostridium difficile infection (CDI) affects 20-30% of patients following successful treatment of an
initial disease episode. It is hypothesized that the gut microbiota, the microbial community within the
gastrointestinal tract, is involved in the development of and recovery from recurrence. Microbial-based
treatments that promote the growth of `healthy' bacteria, such as fecal microbiota transplantation (FMT), have
emerged as an effective treatment method for recurrent CDI. Nevertheless, there is a fundamental lack of
knowledge of the microbes responsible for functions that contribute to colonization resistance against C.
difficile. We have characterized a murine model of recurrent infection, and observed that murine fecal material
from healthy mice is capable of mediating efficient clearance of C. difficile. Previous studies using germ-free
mice have successfully established colonization resistance against C. difficile with human microbiota. Contrary
to this, we observed that FMT from healthy humans did not resolve CDI in our model. While both FMT
treatments changed the microbiota composition, we observed deficient levels of several metabolites. Our
mouse model of recurrent CDI provides us with a method to understand how community structures assemble
to provide colonization resistance against CDI, enabling us to differentiate the critical microbial features in
colonization resistance against C. difficile. We hypothesize that the metabolic environment that limits C. difficile
colonization and growth is dependent on the assembly of succinct microbiota communities. The scientific
objective of this proposal is to elucidate the link between the structure and function of a microbial community
capable of mediating resistance to or recovery from CDI. We aim to do this using the following specific aims: 1)
define structural features in microbial communities that mediate colonization resistance to C. difficile and 2)
identify metabolic pathways in microbial communities that resolve CDI. The training objective of this proposal is
to complement the trainee's background in microbial ecology with bioinformatic and experimental skills that
focus on functions of microbial communities to support transition of the candidate into an independent,
translational investigator. Completion of these aims will result in more comprehensive knowledge of how
microbes function to provide colonization resistance, aiding the critical need to prevent or treat CDI, an
important healthcare-associated infection. In conjunction with the exceptional mentoring team and institutional
environment, this proposal will provide the candidate with scientific skills and career mentorship to become an
independent investigator in an inter-disciplinary field encompassing both microbial ecology and infectious
disease.

Public health relevance
PROJECT NARRATIVE The objective of this proposal is to elucidate the link between the structure and function of a microbial community capable of mediating resistance to or recovery from Clostridium difficile infection (CDI), an important healthcare-associated infection. To identify microbes with critical functions in communities resistant to C. difficile, we will compare metagenomic features of different community structures in a humanized mouse model of recurrent CDI. This proposal is relevant to NIH's mission to foster research that broadens our knowledge and innovates new developments to improve human health by targeting treatment and prevention of CDI.